Differential diagnosis of Parkinson's and multiple system atrophy in non-human primate models using a novel a-synuclein retinal contrast agent and AI-assisted analytics

Project Summary
Parkinson’s Disease (PD) is the second most common neurodegenerative disease after Alzheimer’s disease,
and a major cause of disability in individuals over 65 years of age. PD belongs to a spectrum of diseases termed
the “synucleinopathies”, defined by the progressive aggregation of insoluble fibrillary a-synuclein, and includes
other disorders such as multiple system atrophy and Lewy body dementia. Currently, there are no objective tests
that can be used to definitively diagnose PD. In addition, differential diagnosis of synucleinopathies is very
challenging and relies heavily on a physician's clinical evaluation. A critical goal in the field is to reliably identify
synucleinopathies at early, asymptomatic stages of the disease, to allow the best chance for correct disease
modifying or preventative treatments to be effective. This proposal aims to develop a small molecule fluorescent
retinal contrast agent as a novel diagnostic for PD and other related synucleinopathies.

Public health relevance
Project Narrative Parkinson’s disease (PD) and multiple system atrophy (MSA) are age-related synucleinopathies defined by the presence of α-synuclein deposits. Accumulation of α-synuclein has been identified in retina of patients with PD. The proposed research aims to advance the first diagnostic to image α-synuclein deposits in the eye with a novel contrast agent.